Role of Smooth Muscle Cell Insulin Resistance and Systemic Metabolic Dysfunction in Atherosclerosis Development and Late Stage Lesion Pathogenesis

Atherosclerosis is a leading cause of death in the USA and globally due to myocardial infarction (MI) or stroke. Despite
statin treatment to reduce LDL cholesterol, its incidence is on the rise due to the global epidemic of obesity, metabolic
syndrome (MetS), and early onset type-2 diabetes (T2D). Indeed, more than half of the mortality in T2D is caused by
cardiovascular complications. Human histopathological studies have shown that lesions prone to plaque rupture, with
catastrophic thromboembolic events like MI or stroke, have a thin fibrous cap and a high CD68+/ACTA2+ [presumed
MФ/smooth muscle cell (SMC)] cell ratio. These characteristics occur at a higher prevalence in atherosclerotic
lesions of diabetics and in women versus men. However, we have a poor understanding of the mechanisms by which
insulin resistance, hyperglycemia, and other metabolic abnormalities in T2D-MetS exacerbate atherosclerotic
disease. We recently demonstrated that although multiple cell types contribute to formation of the ACTA2+ fibrous
cap, long-term plaque stability is dependent on SMC. Moreover, we showed that aerobic glycolysis, a pathway
dysregulated in T2D is required for transition of SMC to a beneficial myofibroblast (MF)-like state critical for formation
and maintenance of a stable fibrous cap. Results are of major interest given studies of Clemmons and co-workers
showing that SMC-selective knockout of insulin receptor substrate-1 (IRS1), a protein required for insulin and insulin-
like growth factor-1 (IGF1) signaling, resulted in de-differentiation of SMC, hyper-proliferation, and increased
neointimal formation following femoral artery injury. However, they did no atherosclerosis studies and did not consider
that de-differentiated SMC could have beneficial or detrimental effects on lesion pathogenesis depending on the
nature of their phenotypic transitions. Studies in this proposal will test the hypothesis that insulin-IGF1 resistance
in SMC combined with metabolic abnormalities including the profound hyperglycemia and hyperlipidemia
associated with T2D-MetD results in detrimental (plaque de-stabilizing) changes in SMC phenotype. Aim 1 will
determine if insulin-IGF1 signaling in SMC is required for their investment into the fibrous cap and transition to a
plaque stabilizing MF phenotype. Aim 2 will determine if global insulin resistance and the associated metabolic
changes, including hyperglycemia, promote atherosclerosis development and late-stage lesion pathogenesis by
inducing detrimental changes in SMC phenotype. Aim 3 will determine potential mechanisms by which impaired
insulin-IGF1 signaling in SMC contributes to late-stage lesion pathogenesis in humans with T2D/MetS. Studies
include: 1) use of our novel SMC lineage tracing atherosclerotic mice with global or SMC-specific insulin
resistance with or without systemic metabolic dysfunction including hyperglycemia and hyperlipidemia; 2)
rigorous analysis of indices of plaque stability and phenotypic transitions of SMC and other lesion cells; 3)
genomic studies to identify genes and pathways whereby T2D-MetS promote plaque-destabilizing changes in
SMC phenotype; and 4) human validation studies. Our ultimate goal is to identify novel therapeutic interventions
for promoting increased plaque stability in patients with T2D-MetS.

Public health relevance
Project Narrative/Relevance: Atherosclerosis is a progressive cardiovascular disease that remains the leading cause of death in the USA and worldwide in spite of widespread use of statins, other lipid lowering therapies, and life-style modifications. Of major concern, the incidence of symptomatic atherosclerosis in younger individuals is rising at an alarming rate primarily due to the global epidemic of obesity and early onset type 2 (insulin resistant) diabetes (T2D) and the associated metabolic disease (MetD) characterized by insulin resistance and increases in blood glucose, insulin, triglycerides, and cholesterol levels. Indeed, numerous high quality studies provide evidence that each of these factors may contribute to accelerated atherosclerosis development, progression, and end stage disease pathogenesis including rupture of the protective fibrous cap overlying advanced atherosclerotic lesions resulting in a heart attack or stroke. However, a major unresolved question is which if any of the T2D/MetD associated changes impair the ability of smooth muscle cells (SMC) or other cell types to form and maintain the protective fibrous cap. The goals of studies in this proposal are to address this question, and to identify novel therapeutic approaches to enhance the ability of these cells to form and maintain a thick and mechanically robust fibrous cap (i.e. analogous to a stronger patch on a tire) even in the context of T2D/MetD.